RNA methylation and mesenchymal stem cell differentiation

Project Summary
Mesenchymal stem cells (MSCs) can develop into osteoblasts, adipocytes, and chondrocytes, providing
materials for regenerative medicine. In particular, bone-related applications of MSCs is one of the most promising
clinical applications of MSCs. The PI recently found that Fkbp4, a member of the FK506-binding protein (Fkbp)
family of peptidyl prolyl isomerase (PPIase), promotes MSC differentiation into osteoblasts. They also found that
Fkbp4 interacts with the Mettl3 complex, which induces the novel RNA modification called N6-methyladenosine
(m6A). Although m6A is known to be involved in MSC differentiation, exact roles and mechanisms remain largely
unknown. Through a genome-wide approach, PI found thousands of mRNAs modified by m6A in MSCs,
osteoblasts, and adipocytes. The mRNAs included critical transcription factor genes for the differentiation as well
as several histone modifying enzyme genes. In addition, they found that Fkbp4 activates the Mettl3 complex in
a PPIase domain-dependent manner. Based on these findings, the PI hypothesized that Fkbp4 activates the
Mettl3 complex by isomerization of one of its subunits during osteoblast differentiation. They also hypothesized
that m6A modifications promote osteoblast differentiation by modulating RNA metabolism with a result of
increased protein levels of the genes. The PI will test these hypotheses with the following three aims. In Aim 1,
the PI will map m6A distributions in the transcriptome of MSCs, osteoblasts, and adipocytes at a single nucleotide
level. Subsequently, they will inhibit the methylation in a sequence-specific manner to understand causal
relationships between m6A and RNA metabolism. Aim 2 will investigate bone phenotypes of Fkbp4 knockout
mice and also study how m6A of osteoblast genes affect their differentiation. Aim 3 will study m6A modification
of Fkbp4 mRNA as a feedback between Fkbp4 and Mettl3. In addition, this aim will investigate how Fkbp4
expression is inhibited during adipocyte differentiation by glucocorticoid receptor. Collectively, these studies will
demonstrate a novel regulatory mechanism of Mettl3 by Fkbp4 and how m6A modifications controls MSC
differentiation. These findings are expected to promote MSC-based regenerative medicine.

Public health relevance
Project Narrative This project will study how differentiation of mesenchymal stem cells is regulated by RNA methylation and how the methylation is controlled by the protein isomerase Fkbp4. Results of this study will contribute to better understanding and manipulation of mesenchymal stem cells for regenerative medicine and other applications.